Pain Disengagement Training: A self-directed intervention for pain catastrophizing

PROJECT SUMMARY
This career development award proposal describes a research and training plan that will provide Dr. Katherine
McDermott with the resources needed to establish a career as an independent clinical scientist developing and
testing scalable interventions for the treatment of chronic pain. Background: Chronic musculoskeletal pain is
one of the leading causes of disability, with millions of individuals suffering from its effects. Pain catastrophizing
is a key predictor of pain interference and is characterized by magnification of the intensity of pain, rumination,
and feelings of helplessness to cope. While some interventions target pain catastrophizing, they offer modest
effects and require extensive resources due to reliance on clinician involvement. Self-directed interventions that
parsimoniously and effectively target pain catastrophizing are needed. Specific aims and research design: This
project will involve the development, refinement, and preliminary evaluation of Pain Disengagement Training
(PDT), a self-directed intervention for pain catastrophizing. The aims of this project are 1) To develop PDT using
qualitative focus groups to solicit patient input on intervention components and protocol considerations (N=4
groups, ~20 participants); 2) To refine PDT using an open pilot (N=10) with pre/post intervention self-report
assessments and qualitative exit interviews to obtain feedback on the intervention experience and procedures; and
3) To evaluate the feasibility, acceptability, and credibility of PDT in a pilot randomized controlled trial (N=50)
of PDT vs. Healthy Writing Control (HWC). Results will inform a multi-site feasibility RCT R01 submission.
Training and mentoring: Three primary training aims will be accomplished in the present proposal to fill key
gaps in the candidate’s training: 1) Qualitative and mixed methods, including the design of focus group procedures
and qualitative and mixed methods data analysis; 2) Chronic pain intervention development and refinement,
including developing protocols to optimize intervention acceptability and feasibility in a pain patient sample; and
3) Management of rigorous randomized clinical trials, including establishing standard operating procedures to
maximize fidelity and retention. This training will be provided by a team of expert mentors including Dr. Ana-
Maria Vranceanu, Dr. Francis Keefe, and Dr. Mark Lumley, who have a wealth of experience designing and
evaluating interventions for chronic pain. Additional training will be provided by advisors (Drs. Parker and
Yousif), didactics, scientific publications, and experiential training, including manuscript writing. Relevance to
NCCIH: This study is well-aligned with NCCIH’s focus on Whole Health research and support of impactful
clinical trials of complementary and integrative health approaches, including the advancement of the
complementary and integrative management of pain. Impact: The proposed project and training plan will provide
the candidate with the training needed to transition to independence as an intervention researcher committed to
creating scalable treatments to address the key predictors of chronic pain interference.

Public health relevance
PROJECT NARRATIVE The proposed study will evaluate the feasibility and acceptability of “Pain Disengagement Training,” a novel, self-directed intervention for chronic pain. PDT targets pain catastrophizing, including the tendency to magnify the intensity of and ruminate on the experience of pain, which is a key predictor of the extent to which pain interferes in an individual’s life. Due to its self-directed nature, PDT has great potential to reduce the burdensomeness of pain in a large number of patients suffering from this chronic and often disabling condition.